Generalizing genome editing for rare disease-causing variants

PROJECT SUMMARY
The latest generations of base editing and prime editing tools can efficiently install genetic
variants and correct those associated with disease. However, it is still not practical to treat most
patients with rare or unique disease-causing genetic variants because the cost and effort required
to optimize an editing strategy and bring it to the clinic is prohibitive. Existing editing therapeutics
approved or in clinical trials are all applicable to treat either a common disease-associated allele
or a large set of potential disease-associated alleles. For example, the recently approved Casgevy
genome editing treatment can be used to cure patients with nearly any beta-thalassemia or sickle
cell disease genotype, including rare and common variants. For most types of rare genetic
disease, no known genome edit could treat multiple disease-associated alleles. This proposal
describes methods to establish generalizable editing strategies that would each be broadly
applicable to treat hundreds of rare disease-causing genetic variants, helping to bring the benefits
of genome editing to the patients who need them.
Two classes of generalizable therapeutics are proposed here. One will address rare loss-
of-function alleles such as haploinsufficiencies, recessive hypomorphic alleles, and diseases
where expression of a paralogous gene could provide the lacking function. The other class of
therapeutics will address rare gain-of-function alleles by allele-specific knockout. These
conceptual strategies will be studied in the context of Marfan’s Syndrome, vascular Ehlers Danlos
Syndrome, adrenoleukodystrophy, and Charcot-Marie-Tooth Disease. Success would motivate
adapting the same development platforms to a plethora of other forms of rare genetic disease.
In addition, this proposal aims to establish safer and more effective delivery of genome
editors by adeno-associated viral (AAV) vectors, which would be best suited to access the target
tissues to correct the above disorders. While AAV delivery of genome editors has proven to be
effective in a range of mouse models of genetic disease, it has not been deployed in the clinic
due to concerns of continued off-target editing and immunogenicity of the editor. This proposal
will overcome the limitations that prevent adapting base editor and prime editor tools to drug-
inducible vectors. By establishing potent and drug inducible genome editing AAVs, it will be
possible to avoid sustained off-target editing and immunogenicity once the therapeutic editing is
achieved.

Public health relevance
PROJECT NARRATIVE I will establish generalizable genome editing strategies to treat rare disease-causing variants in an efficient and variant-agnostic manner, overcoming the key challenge that prevents widespread applicability of genome editing therapeutics to rare disease. I will adapt editors to drug-inducible viral vectors to permit safer, more transient in vivo delivery. Success in establishing these methods would enable the treatment of over one hundred genetic diseases caused by individually rare variants.